Development of a first-in-class combination of DNA damage response inhibitors for the treatment of high-grade serous ovarian cancer

PROJECT SUMMARY
High-grade serous ovarian carcinoma (HGSOC) is a devastating disease responsible for the deaths of ~125,000
women worldwide each year. HGSOC has the lowest survival rates. More than 20% of HGSOCs harbor genetic
mutations (e.g. BRCA1/2MUT) that cause defects in homologous recombination (HR), which causes sensitivity
to PARPi. However, responses to PARPi are rarely durable and resistance is acquired rapidly. Another 50% of
HGSOCs do not harbor defects in HR and instead overexpress Cyclin E (CCNE1) through amplification, copy
number gain, or transcriptional means. Unlike BRCA1/BRCA2-mutant tumors, which initially respond to platinum-
based chemotherapy, CCNE1-amplified tumors are associated with primary platinum failure. A recent study
revealed that 1) Cyclin E (CCNE1) induction increases ATR signaling and sensitivity to WEE1 kinase inhibitor
and ATR inhibitor (WEE1i-ATRi) treatment, 2) WEE1i-ATRi increases tumor regression in a CCNE1-level-
dependent manner in PDXs, 3) Differential molecular effects of WEE1i and ATRi promote replication fork
collapse, and 4) CCNE1 amplification is a reliable biomarker predictive of response to WEE1i-ATRi. These
findings indicated that a combination of WEE1 kinase inhibitor (WEE1i) and ATR inhibitor (ATRi) is a feasible
approach for the treatment of PARPi-resistant Cyclin E (CCNE1) overexpressing (CCNE1HIGH) high-grade serous
ovarian cancer (HGSOC). These results provide a strong rationale for Atrin to develop a first-in-class combination
of WEE1i and ATRi that can allow lower-dosing strategies to mitigate off-target toxicity for the treatment of
HGSOCs. Atrin Pharmaceuticals, Inc has been in the field of DDR for over a decade and is pioneering the
development of next-generation, selective ATRi. We have discovered ATRN-119 as a highly selective ATRi and
have received FDA IND approval (IND #141317). In parallel, we have also discovered a highly selective WEE1
inhibitor demonstrating high potency on WEE1 kinase, superior selectivity over PLK1, and significant anti-growth
activity against various cancer cell lines of NCI-60 panel with high potency. In addition, our WEE1i exhibits
superior potency in OVCAR8 cells compared to AZD1775. Pharmacokinetic (PK) study in mice shows superior
oral bioavailability compared to AZD1775. In an OVCAR-3 xenograft tumor model, it alone completely halts tumor
growth without causing loss of body weight. Importantly, our WEE1i sensitizes the ovarian cancer cell line
(OVCAR8) to ATRN-119. Given these promising results, we proposed to 1) Quantify sensitivity of HGSOC to our
WEE1i and ATRN-119 alone as well the combination in PDX models of HGSOC. 2) Identify additional biomarkers
to expand target patient populations, 3) Evaluate the toxicity, and 4) Obtain a GMP batch of API. The success
of our Direct-to-Phase II project will further support chemistry, manufacturing, and controls (CMC) to manufacture
clinical supply of our novel WEE1i and complete FDA-required IND-enabling pharmacology safety and toxicology
studies. In addition, findings from this project will inform clinical trial protocols using our first-in-class combination
for the treatment of HGSOC, which critically needs more efficacious treatments.

Public health relevance
PROJECT NARRATIVE High-grade serous ovarian carcinoma (HGSOC) is a devastating disease that critically needs more efficacious treatments. Atrin Pharmaceuticals, Inc is developing a first-in-class combination of novel DNA damage response inhibitors for the treatment of HGSOC.